Intergenerational Health Study

The overarching goal of this study is to establish a large offspring cohort to investigate the long-term intergenerational impacts of GDM and obesity on the metabolic, vascular, and reproductive health of the offspring. In the present study, we will apply a hybrid design which combines maternal and offspring data that have been prospectively and longitudinally collected with newly collected data. This study will leverage ongoing mother-offspring cohorts, the Nurses' Health Study II (NHS-II; mothers) and the Growing Up Today Study (GUTS; offspring) in the United States and the mother-offspring pairs in the Danish National Birth Cohort (DNBC) in Denmark. We leveraged the Danish National Birth Cohort (DNBC) in Denmark for biospecimen analysis of markers of metabolic and reproductive function. The project remains on hold pending resolution of data sharing policies with Denmark under EU GDPR.